Brain, Blood, and Iron: advances in the cell biology of neurodegeneration

DESCRIPTION (provided by applicant): The neuroacanthocytosis (NA) and neurodegeneration with brain iron accumulation (NBIA) syndromes are two groups of very rare genetic disorders, characterized by neurodegeneration affecting primarily the basal ganglia. Clinical, laboratory and neuropathological features suggest common methods of cell death. The proposed meeting will bring together researchers from a variety of fields which are likely to shed light upon the pathophysiology of these disorders.

Public health relevance
The proposed meeting brings together researchers with expertise of relevance to several rare genetic neurodegenerative disorders. Elucidating mechanisms of cell death in these disorders may shed light upon facets of cell biology such as iron metabolism and membrane structure of general neurobiological significance.